Olfactory Coding in Ventral CA1 Region of the Hippocampus

PROJECT SUMMARY/ABSTRACT
Olfaction is an evolutionarily conserved sensory system, and olfactory cues uniquely interact with limbic functions
including memory and emotion in healthy individuals. Deficits in olfaction are a common finding in multiple
neurodegenerative diseases that also disrupt memory and emotion. However, the mechanisms underlying these
olfactory deficits, as well as those underlying normal olfactory-limbic functions, are unknown. Previous studies
show that strong reciprocal anatomical connections link primary olfactory brain regions, including the posterior
piriform cortex (pPIR) to limbic structures, including the ventral CA1 region of the hippocampus (vCA1). vCA1 is
connected to primary olfactory brain regions via polysynaptic connections through the entorhinal cortex, but
recent studies have also established monosynaptic projections to vCA1 directly from pPIR, which may provide
another feedforward route by which olfactory information can reach vCA1. The structure of these connections
and their role in encoding and integrating olfactory information remain poorly understood. Additionally, while
odorant-tuning has been previously reported in dorsal hippocampal neurons, odor responses in vCA1 remain
uncharacterized. The central hypothesis of this proposal is that vCA1 receives olfactory information along
structured projections from pPIR and encodes information about odor identity in patterns of neuronal activity. In
Aim 1, neuroanatomic studies will identify principles of spatial organization of feedforward projections from pPIR
to vCA1. Viral-based tracing approaches will be used to elucidate the cell-types in pPIR that project to vCA1 and
to determine the topographic organization of their axonal arborizations within vCA1. In Aim 2, neurophysiologic
studies will determine the coding of olfactory stimuli in vCA1. Extracellular electrophysiology will be used to
record vCA1 responses during presentation of olfactory stimuli, and the coding of odorant identity in single
neurons and populations of neurons will be evaluated using statistical and computational approaches. This
proposed study advances Theme 1 of the NIDCD’s 2023-2027 Strategic Plan to identify and characterize neural
circuits involved in normal central olfactory processing. The short-term significance of this research is that it will
provide fundamental basic science knowledge of the structure and function underlying healthy olfactory coding
in a higher-level limbic brain region. The long-term objective is to enable future studies of central mechanisms
underlying olfactory deficits in neurodegenerative diseases known to affect ventral hippocampus. This research
training project will be carried out by the applicant in the Padmanabhan Laboratory at the University of Rochester.
This environment is optimally suited to providing the applicant training in advanced computational approaches
for neuroanatomic and neurophysiologic analyses and professional development in the field of chemosensory
research. This training fellowship will prepare her to perform independent research on chemosensation within
the field of neurology as a physician-scientist.

Public health relevance
PROJECT NARRATIVE This research will contribute fundamental insights into what role ventral hippocampus, a part of the brain involved in memory and emotion, plays in sense of smell. In the short term, this research will provide knowledge about the structure of neural connections that may carry odor information from the primary olfactory cortex directly to ventral hippocampus, and it will define the responses of single-cells and groups of cells in ventral hippocampus to odors. In the long term, these investigations will inform scientific studies into why sense of smell is affected in neurodegenerative diseases.